Effect of ILC3 loss on epithelial barrier function during ART Treated HIV infection

Project Summary:
Our project aims to investigate the mechanisms behind the loss of Type 3 innate lymphoid cells (ILC3) in
antiretroviral therapy (ART) treated People Living with HIV (PLWH) and the subsequent impact on intestinal
epithelial barrier integrity. Chronic immune activation is a hallmark of HIV infection that persists in PLWH on ART
and is linked to non-infectious comorbidities. Microbial translocation (MT) due to decreased mucosal barrier
integrity is in part responsible for driving HIV-associated inflammation. Therefore, it is critical to understand
mechanisms underlying barrier integrity in ART treated PLWH. ILC3s are essential for the maintenance of the
gut epithelial barrier and are depleted during early HIV infection and are not restored with ART. Decreased
frequency of these cells during HIV infection likely contributes to decreased epithelial barrier integrity leading to
increased MT. Since ILC3s are not susceptible to direct HIV infection and a viable model to study their loss has
yet to be developed, the mechanism behind their loss remains poorly understood. To address this gap in
knowledge, we will use human intestinal explants as a model system to study early HIV infection. These explant
tissues contain ILC3s, epithelial cells, and other immune cells that are susceptible to HIV infection. Our
preliminary data show that these explant tissues remain viable for up to 7 days, can harbor HIV infection and
ILC3s are depleted following HIV infection, providing this as a viable model to study HIV-associated ILC3
depletion. Furthermore, we and others have shown that ILC3s respond to specific bacteria found in the gut
microbiome. This is emphasized as PLWH have a distinct enteric microbiome that is not reverted with ART. To
fully model the intestinal environment during HIV infection, and the subsequent impact on ILC3 function, we will
introduce an HIV-associated microbiome to the intestinal explant tissues. Ultimately, using these explants with
HIV infection and HIV-associated microbiomes will shed light on the underlying mechanisms behind the loss of
ILC3s and the effect on intestinal epithelial barrier integrity. This understanding could lead to the development
of new therapeutic approaches to improve barrier integrity and reduce HIV-associated inflammation and
comorbidities in PLWH.

Public health relevance
Project Narrative: Using a novel human intestinal explant model, this project aims to understand the mechanisms behind the loss of Type 3 innate lymphoid cells (ILC3) in People Living with HIV (PLWH) on antiretroviral therapy (ART) which is associated with decreased epithelial barrier integrity, increased microbial translocation and chronic immune activation. The ultimate goal is to shed light on the underlying mechanisms, including changes in the gut microbiome, behind ILC3 depletion and its effect on intestinal health to improve chronic immune activation in PLWH.